Clinical Core

Project Summary – Clinical Core (CC)
The Clinical Core (CC) is critical to the function of the Indiana Alzheimer’s Disease Research Center (IADRC).
A major emphasis is to identify and clinically characterize patients with preclinical and early symptomatic stages
of AD, including early and late onset AD, as well as asymptomatic, early symptomatic, and affected individuals
from families with hereditary AD, genetically distinct non-AD dementia, and the presently enrolled sporadic
frontotemporal dementia cases. The CC will support NACC, NCRAD and other local, regional, national and
international projects by obtaining and facilitating the banking and storage of neuroimaging data as well as blood,
DNA, peripheral blood RNA, plasma, serum, CSF, peripheral blood mononuclear cells (PBMC) and postmortem
brain samples from our research participants for further characterization by the Neuroimaging Core (NIC),
Genetics, Biomarker, and Biospecimen Core (GBBC), Neuropathology Core (NPC) and the Data Management
and Statistical Cores (DC). Patients from the CC will be offered as appropriate participation in ADNI, DIAN,
LOAD, investigational drug trials and other local and multicenter research studies. In addition, we will collaborate
with the Research Education Component (REC) and the Outreach, Recruitment, and Engagement (OREC) Core
to provide education and training opportunities to researchers and trainees at all levels and to educate and
support affected participants, family members, and the community at large.